Research Infrastructure Core

ABSTRACT
The U54 Center for Translational Research in Health Disparities (CTRHD) Research Infrastructure Core (RIC) will provide
support for the pilot grants funded through the Investigator Development Core as well as for the Morehouse School of
Medicine (MSM) community at large. The RIC will be composed of four major components: Study Design, Biostatistics,
and Data Management Core (SDBDMC) will provide support of biostatistics, epidemiology and computational services to
biomedical, behavioral and clinical researchers; Biomedical Informatics Unit (BIU) will provide informatics and data
management services; Clinical Research Core will provide support for clinical researchers; Translational Technologies
Program (TTP) will provide equipment and lab services to support the proposed research. By combining these three existing
services into one structure we will provide a “one stop” location for the researcher to initiate and maintain their research
projects. Providing infrastructure to investigators has been a key component to the RCMI mission since its inception. This
has been an effective strategy in developing key equipment and services to support and maintain the mission of MSM. It
has been particularly important in developing junior faculty who have basic lab and data service needs to help bootstrap
their research programs and allow them to become productive earlier in their careers. It has also been an effective strategy
for allowing clinical faculty to have access to technology and expertise needed to advance translational research. Beyond
the availability of equipment, the cores also provide access to expertise to assist in the use of advanced technologies to
promote research. The RIC also provides a framework to train students and postdocs to gain essential skills in technology
that are not available in individual researcher labs. The RIC will also serve as the gateway for investigators to access
technologies in other facilities. We work together with other institutions such as Emory University, the Georgia Institute
of Technology, and Georgia State University via cooperative agreements through the Georgia Clinical and Translational
Research Alliance (GaCTSA) and others to expand the availability of advanced technologies to all researchers at MSM.
The RIC is a crucial component of the CTRHD that will accomplish it goals through the following aims:
Aim 1: Transform Our Institution: Rework our capacity to deliver analysis and technical expertise.
Aim 2: Transform Our Research Environment: Provide a robust research infrastructure that fosters innovative,
multidisciplinary biomedical/translational research.
Aim 3: Transform the MSM Community of Biomedical Scientists: Provide institution-wide resources leveraging and
integrating research project support and training enhancing the research training and career development environment.
Aim 4: Transform Our Community. Facilitate external interactions with partners and the community we serve.